Biology Core

Project Summary – Core C

The Cell Biology Core provides major resources to the program project investigators, including normal human
cells, an extensive library of characterized melanoma cell lines and patient-­derived xenografts (PDX) (Objective
1). The melanoma cell line library encompasses >400 cell lines, at least 200 with known genetic status. To
exclude cross-­contamination, all experimental cell lines are fingerprinted. Our normal cell panel includes:
melanocytes, keratinocytes, fibroblasts, endothelial cells, and skin-­derived stem cells. The PDX panel
encompasses now >500 specimens. They have been characterized for metastasis formation and ~250 have
been analyzed for mutations in 108 cancer-­related genes. Approximate 50 have been subjected to Whole Exome
Sequencing and RNAseq. >350 PDX have been analyzed for expression of >300 proteins. We expect that all
PDX will be analyzed during the course of the grant at a genome wide level for abnormalities at the DNA, RNA
and protein levels. Other resources include a lentiviral vectors for growth factors, adhesion molecules, and
oncogenes and monoclonal antibodies to melanoma-­associated biomarkers.

Three-­dimensional cultures of normal human skin (skin equivalents or organotypic cultures of skin) with a dermis
of fibroblasts embedded in collagen and an epidermis of melanocytes/melanoma cells and keratinocytes, are
also continuously available to the program investigators (Objective 2). This three-­dimensional model is superior
to standard cell culture techniques because it mimics the in vivo microenvironment for the
melanocytes/melanoma cells. For screening studies the Core is providing a robotics-­assisted spheroid culture
model that allows investigations on melanoma cells displaying in vivo relevant architecture, cell-­to-­cell contacts
and invasion, in the presence of a collagen support matrix. Spheres are enriched in cancer stem-­like cells and
can be used instead of spheroids. The Core additionally provides subcutaneous melanoma growth models for
standard experiments, including patient-­derived xenografts that are exclusively maintained in vivo and using
tissues provided by the Pathology Core B. A variety of metastasis models are available as are humanized mice
to study the interactions of immune cells with tumor cells.

Public health relevance
Project Narrative – Core C This core supports the research projects with cell- and animal- based experimental tools and models, but also conducts experiments. The infrastructure encompasses libraries of human melanoma cell lines, viruses and antibodies, skin and tumor growth models, each reflecting different aspects of melanoma biology in patients. Most recent developments have added the capacity of the core to conduct testing of compounds and to investigate host cell- tumor cell interactions.